Nitric oxide induced soluble guanylate cyclase dysfunction or activation: Implications as a disease indicator or in therapy

ABSTRACT
Hemeproteins are essential for life, and heme insertion is an essential step in their maturation and function.
Although the mechanisms by which mammals insert heme during hemeprotein maturation are mostly unknown,
studies from our group uncovered a specific involvement of the chaperon hsp90 in heme insertion into four key
hemeproteins, inducible nitric oxide synthase (iNOS), soluble guanylyl cyclase (sGC), hemoglobin (Hb) and
myoglobin (Mb). Our studies indicate that a strong sGC-hsp90 interaction can be a measure of heme-free sGC
in cells and that this interaction is mutually exclusive with respect to sGC-subunit heterodimerization. Together,
these findings have potential applications in the clinical diagnosis of diseased conditions where sGC is
dysfunctional. We discovered that sGC becomes dysfunctional in inflammatory asthma under elevated nitric
oxide (NO), which impedes the NO-based bronchodilation, but can be overcome by sGC activators which can
induce bronchodilation despite this loss. Such sGC dysfunction in asthma is associated with a strong molecular
signature of sGC dysfunction which comprises of a weak sGC-α1β1 heterodimer, a strong sGCβ1-hsp90
interaction and a high S-nitrosylation (SNO) on sGC-β1. Our current and past studies have revealed that NO
levels are critical in biology and can act both ways to make or break sGC. While high NO levels as in asthma
can induce sGC dysfunction by breaking the sGC-α1β1 heterodimer, low NO levels can trigger heme-insertion
in sGC-β1, increasing and stabilizing the sGC heterodimer. Moreover in human asthmatic ASMCs (airway
smooth muscle cells), our studies suggest that sGC is unresponsive to NO due to it being heme deficient, but
can be activated by sGC activators. Based on these exciting new findings we propose (i) molecular and cellular-
level studies to define mechanisms to understand how sGC becomes dysfunctional under high NO as in asthma.
This includes mechanisms to determine whether a denitrosylase such as thioredoxin-1 (Trx-1) or Hb present in
the apical epithelium (as A549 cells express Hb in our new find) can have a protective role for underlying airway
smooth muscle sGC. (ii) Establish, whether a defective sGC heme exists in asthmatic HASMCs (human airway
smooth muscle cells) or in mouse models of asthma (OVA, CFA/HDME) causing defective bronchodilation,
explore the basis of this heme-deficient sGC and firmly establish the molecular signatures of sGC dysfunction in
human asthma, such that this can be applied in future as a dysfunction indicator of sGC in blood platelets of live
asthma patients. (iii) Finally coupling the effect of low NO levels in inducing sGC heterodimerization, and
overexpressing enzymes which are downregulated (Hsp90, Trx-1, Catalase) in asthmatic HASMCs, we propose
to restore sGC dysfunction in such HASMCs that display a predomiant heme-free sGC phenotype. Together our
project will advance the current knowledge of how hsp90, NO and inflammation can regulate sGC maturation,
and will provide new information on sGC maturation in healthy and asthmatic airways.

Public health relevance
PROJECT NARRATIVE Our current findings provide new insight on how the sGC signaling enzyme becomes dysfunctional toward nitric oxide (NO) in inflammatory asthma. Our findings reveal a clearly defined molecular signature of sGC dysfunction in asthma that impedes the NO-based bronchodilation, which can be overcome by sGC activators by inducing bronchodilation and such sGC activators could be new bronchodilators for asthma. Our proposal stands to reveal cellular mechanisms by which sGC becomes dysfunctional in asthma, establish the hallmarks of sGC dysfunction in human asthma, will explore pathways to restore sGC dysfunction and better stabilize the lung sGC heterodimer in airway smooth muscle cells (ASMCs) from asthma.